Molecular and cellular underpinnings of placental malaria

PROJECT SUMMARY/ABSTRACT
Malaria in pregnancy poses significant threat to the wellbeing of the mother, fetus, and neonate and in sub-
Saharan Africa, it kills 100,000 infants annually and accounts for about 20% of stillbirths. These fetal adverse
outcomes are mainly due to the sequestration of Plasmodium falciparum-infected erythrocytes in placental
intervillous spaces, resulting in placental malaria (PM). This happens even when malaria infection is
asymptomatic and undetectable in maternal blood. The burden of PM is worsened by rising resistance to
intermittent preventive treatment with sulphadoxine-pyrimethamine (IPTp-SP), which is recommended for
malaria chemoprophylaxis during pregnancy. Indeed, our data show that many women on IPTp-SP who test
malaria negative and are asymptomatic, still have PM. PM is associated with several adverse effects on the
fetus, including fetal growth restriction, preterm birth, and neonatal morbidity and mortality. The adverse
outcomes are mainly due to placental injury and not fetal infection by Plasmodium falciparum, which is rare.
Since the placenta is inaccessible during pregnancy, the impact of PM on placental biology is unclear, and there
are no tools for PM detection during pregnancy, representing a critical research gap. These factors and the
limited understanding of the effects of PM on placental function and physiology significantly hamper the
development of effective PM interventions and diagnostic tools. However, the placenta sheds vast amounts of
extracellular vesicles into maternal circulation, offering a non-invasive readout of the fetal environment. To
comprehensively understand the cellular and molecular processes that underlie PM-driven placental
pathobiology, we propose to leverage our well-defined placental biobank to, 1) identify the transcriptomic
signatures of PM-induced placental pathobiology, and 2) identify PM-associated transcriptomic signatures in
maternal circulation. The latter will be implemented by profiling the transcriptome of maternally circulating
placental extracellular vesicles and by identifying placenta-originated cell-free RNA in maternal circulation. These
analyses will uncover processes/factors underlying PM-induced placental pathobiology and those that can be
targeted to prevent or mitigate PM. The identified PM biomarkers will be leveraged to develop effective
point-of-care tools for PM diagnosis in low-resource settings, which have the potential to significantly
improve maternal and child health outcomes. The proposed work will also build a strong foundation in research
networks, infrastructure, skills, and data for follow up studies on the pathobiology of PM and its consequences
for the developing child. Moreover, the strategies, experience, knowledge, tools, and platforms used in this study
can be extended to other common placental infections in sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE Malaria infection during pregnancy causes red blood cells containing the malaria parasite to attach to the placenta, the organ vital for development and growth of the baby during pregnancy. Placenta infection with malaria disrupts placental function and is linked to poor pregnancy outcomes like low birth weight, premature birth, and stillbirth. This proposal will seek to determine the biological effects through which placental malaria alters placental function and identify strategies for exploiting this knowledge for the development of placental malaria interventions as well as tools for placental malaria detection during pregnancy.